Duke/UNC ADAR Program

PROJECT SUMMARY
This application aims to develop, implement, and evaluate an innovative research training program designed to
offer training and support to undergraduate students at Duke University and the University of North Carolina
(UNC) – Chapel Hill from diverse backgrounds to pursue careers in aging research. The long-term goal is to
enhance the diversification of the aging research workforce and promote scientific excellence. Diversity of
thoughts and approaches fosters innovation and creativity, and it is essential for scientific excellence. Yet, it is
well-established that much of the U.S. population scientific talent remains untapped, particularly among persons
from systematically disadvantaged social backgrounds. For example, while Hispanics/Latinos comprise nearly
20% and Blacks/African Americans 13% of the U.S. population, they represent less than 5% and 2% of R01-
awardees, respectively. The proposed Duke/University of North Carolina Advancing Diversity in Aging Research
(Duke/UNC ADAR) program will build on the infrastructure and expertise available at the Duke Center for the
Study of Aging and Human Development (Duke Aging Center) and UNC-Chapel Hill, to develop a collaborative,
state-of-the-art research training program at the forefront of providing training in aging research and resilience
to undergraduate students from diverse backgrounds. This will be accomplished by providing diverse students
at these institutions with 1) mentored “hands-on” paid research experiences, 2) weekly seminars aimed at
enhancing skills and knowledge in aging and resilience research, as well as fostering career development, and
3) facilitated engagement activities with peers, older adults and the scientific community, aimed at promoting
group cohesion, enhance interest in pursuing careers in aging research, and promote a sense of belonging in
science, which will be key to fostering professional resilience. Mentors will include faculty from the Duke Aging
Center and UNC-Chapel Hill with expertise in aging and resilience research. Up to six new students will be
selected every year to participate in this 2-year program. They will be paired with a primary mentor at Duke
University or UNC, and will have access to a larger, diverse network of co-mentors. Together, the student and
primary mentors will develop an Individual Development Plan. There will be rigorous evaluation of the students’
career progress and of the mentoring relationship. Other features of the program will include active involvement
of community leaders, group projects, and mentoring training. Short-term outcome measures will include number
and diversity of students, research presentations, submission of abstracts and feelings of belonging in science.
Mid-term outcomes will include admission to and completion of graduate school. Long-term outcome measures
will include pursuit of careers in research and aging, grant funding and attaining independent scientist status. By
combining the unique strengths of Duke and UNC-Chapel Hill, this program will sow the seeds for the
development of a cadre of diverse scientists with expertise in aging research and promote a strong community
of researchers who are equipped to optimize reserve and resilience among older adults.

Public health relevance
PROJECT NARRATIVE The Duke University/University of North Carolina (UNC) Advancing Diversity in Aging Research Program is an innovative research training program designed to offer training and support to undergraduate students from diverse backgrounds at Duke University and UNC-Chapel Hill to pursue careers in aging and resilience research. By combining the unique strengths of both institutions, this program will sow the seeds for the development of a cadre of diverse scientists with expertise in aging research and promote a strong community of researchers who are equipped to optimize reserve and resilience among older adults.